Functional interrogation of a novel SCGB3A2+/SFTPB+ cell in the human airway

ABSTRACT
This is an adminsitrative supplement request meant to expand the the scope of the parent award “Functional
Interrogation of a Novel SCGB3A2+/SFTPB+ Cell in the Human Airway” (R01 HL166139). In the parent award,
we describe the discovery of a new cell population, defined by a unique gene expression profile
(SCGB3A2HI/SFTPB HI/CFTRHI), lacking markers for other recognized cell types such as club cells
(SCGB1A1) and ionocytes (FOXI1). We termed these as Lower Airway Progenitor (LAP) cells due to their
location within the lung, and preliminary data suggesting that these cells can serve as a progenitor cell. Our
hypothesis, guided by preliminary data, suggested that LAP cells differentiate as early airway progenitor cells
distinct from TP63+ progenitor cells and give rise to a unique subset of airway cell types. The administrative
supplement aims to extend the scope of the project by identifying the transcription factors (TFs) necessary for
LAP cell differentiation and maintenance, using multimodal datasets and computational tools (Aim 1).
Following identification of LAP-enriched TFs, we aim to investigate the function of LAP cell-enriched TFs using
genetic loss-of-function via CRISPRi. The outcome of this project will provide foundational insights into the
regulation, function, and differentiation of this newly identified LAP cell population, contributing to the broader
understanding of human lung biology.

Public health relevance
PROJECT NARRATIVE This proposal will interrogate a novel cell population identified in the developing human lung, referred to as Fetal Airway Secretory (FAS) cells, that are marked by SCGB3A2/SFTPB/CFTR. Since nothing is known about FAS cells, and there is no analogous population in the murine lung, the overarching goal of this proposal is to use an in vitro model of FAS differentiation to describe these cells in detail, to interrogate their differentiation potential, and to determine how they are regulated, thereby providing foundational descriptive and mechanistic insights into a new cell type in the human lung.